Effects of Developmental Alcohol Exposure on Primary and Associative Sensory Cortices

Individuals with fetal alcohol spectrum disorders (FASD) often present sensory alterations such
as sensory overload, attention deficits, delayed auditory processing, and hypersensitivity to
tactile stimulation. There is growing evidence showing that these sensory abnormalities give rise
to social problems and learning deficits. Our lab has developed a ferret model of FASD that
shows remarkable alterations in organization and plasticity of visual areas. For instance, alcohol
exposure during the “third trimester” equivalent of human gestation reduces neuronal plasticity,
decreases individual neuronal orientation tuning and disrupts the organization of orientation
selectivity columns in the primary visual cortex. We propose that the sensory deficits caused by
developmental alcohol exposure are not restricted to visual streams and that aberrant sensory
responsiveness and disrupted integrative properties would also be seen in other sensory
cortical areas. Here we test the hypothesis that abnormal refinement of cortical circuits caused
by deficits in activity-neuronal plasticity caused by developmental alcohol exposure will
dramatically affect cortical sensory processing. We will use a combination of in vivo
electrophysiology and optical imaging of intrinsic signals to test our developmental alcohol
exposures lead to synesthetic responses, with primary cortices displaying high responsivity to
non-dominant sensory modalities (i.e. high responsivity to tactile stimulation in the auditory
cortex); an alteration of tonotopic organization in auditory cortex and a disruption in multisensory
integration in an auditory associative area. These experiments should make a major contribution
to our understanding of sensory deficits in FASD.

Public health relevance
We will use a combination of in vivo electrophysiology and optical imaging of intrinsic signals to test the effects of developmental alcohol exposure in the organization, function and integration in primary and associative cortical auditory areas.